THICKENED CARDIAC BASEMENT MEMBRANES IN CHAGASIC CARDIOMYOPATHY

Electron microscopic studies disclosed marked thickening of basement membranes in myocytes, capillary endothelial cells and vascular smooth muscle cells in myocardium of patients with chronic Chagasic cardiomyopathy.